Pillar: Multi-Modal Imaging AI Models for Breast Cancer Risk

Project Summary:
Accurate cancer risk assessment is critical for the early detection and prevention of breast cancer. With the
foresight from risk models, high-risk patients can receive supplemental imaging and chemo-prevention to
improve their outcomes. Moreover, low-risk patients can follow longer screening intervals and avoid
overtreatment. However, current guidelines rely on inaccurate clinical risk models, limiting their efficacy. To
improve the early detection and prevention of breast cancer, we need accurate cancer risk assessments. To
address this unmet need, we propose to develop Pillar, an AI tool to predict breast cancer risk from longitudinal
multi-modal breast imaging. We hypothesize that AI models that harness multi-modal imaging data will achieve
marked improvements in performance over current risk models, enabling improved cancer guidelines.
In Aim 1, we will develop Pillar, our AI risk model based on longitudinal mammograms, tomosynthesis, and
MRIs. We will create novel machine learning architectures to accommodate massive multi-modal inputs and
novel self-supervised learning algorithms to allow Pillar to capture correspondences between imaging exams.
We will benchmark Pillar against traditional and image-based risk models.
In Aim 2, we will create algorithms to improve the robustness of Image-based AI tools against unseen imaging
protocols. We will develop tools to allow models to adapt to each unexpected input with self-supervised
learning. We will also design novel methods to identify when AI models cannot provide accurate risk
assessments.
In Aim 3, we will develop a simulation framework to benchmark risk-based cancer screening and prevention
guidelines. We will identify metrics to quantify the effectiveness of existing breast cancer screening and
chemoprevention guidelines in simulations across diverse patient populations. Using these metrics, we will
evaluate the ability of Pillar and other Image-based AI models to improve over existing guidelines.
We will develop our tools using our massive imaging datasets from UCSF, ZSGH, and SFMR (San Francisco
Mammography Registry), representing over 350,000 patients. We will validate our findings with external
datasets from Chang Gung Memorial Hospital, Karolinska, and Emory.
If successful, this grant will significantly advance machine learning methods for cancer imaging, introducing
novel neural network architectures, learning algorithms, and robustness approaches. In doing so, it will yield a
new class of image-based AI models for breast cancer risk that can utilize the full spectrum of longitudinal
patient imaging to offer unprecedented accuracy in risk assessment. Our simulation benchmark will show that
Pillar guidelines can improve early detection and prevention while reducing costs and overtreatment. This
study will provide the foundation for future prospective trials, aiming to build a personalized, value-based
approach to care and reshape clinical guidelines.

Public health relevance
Project Narrative: Current national guidelines for the early detection and prevention of breast cancer are inefficient, relying on inaccurate cancer risk models to allocate care. Improved predictors of cancer risk will enable more patients to benefit from early detection and prevention while reducing overtreatment for the rest. To address this unmet need, we will develop AI tools that predict breast cancer risk from multi-modal imaging (Aim 1), build algorithms to improve their robustness to unseen image protocols (Aim 2), and create simulation frameworks to benchmark their clinical utility (Aim 3).